Role of Nod2 and AMP-kinase in obesity-associated liver cancer

Liver cancer is one of the fastest increasing causes of cancer-related deaths in the U.S. and
worldwide. There are approximately 700,000 deaths worldwide each year due to liver cancer. Risk factors
for liver cancer include nonalcoholic fatty liver disease, diabetes, and obesity, and the rising incidence in
these diseases is paralleled with an increasing incidence in liver cancer. The development of hepatocellular
carcinoma, the major subtype of liver cancer, is a multistep process and often starts with chronic
inflammation. However, the molecular and cellular causes of inflammation remain poorly understood.
Nod2 is a bacterial innate immunity protein and Nod2 deficiency is associated with inflammatory
diseases, diet-induced obesity and metabolic dysfunction, and obesity-dependent liver cancer. Preliminary
data, using a mouse model for hepatocellular carcinoma, predicts that the development of liver
tumorigenesis in Nod2-deficient mice on high fat diet (HFD) is associated with an inhibition of the AMP-
dependent kinase (AMPK) pathway. AMPK is a master regulator of metabolic reprogramming and cell
proliferation. However, the role of the AMPK pathway in liver tumorigenesis in Nod2-deficient mice has not
been demonstrated.
In the current project, the hypothesis that there is decreased activation of the AMPK pathway in Nod2-/-
tumorigenic mice, which contributes to the development of hepatic tumors in these mice will be tested. In Aim
1, the role of Nod2 in the activation of the AMPK pathway will be determined. WT and Nod2-/- mice will be
treated with the carcinogen dimethylbenz[a]anthracene (DMBA) and maintained on HFD (DMBA+HFD) to
induce liver tumors and regulation of proteins in the AMPK pathway will be determined in the liver. In Aim 2,
the role of the AMPK pathway in the development of obesity-dependent hepatic tumors in Nod2-/- mice will be
determined. Nod2-/- DMBA+HFD mice will be treated with metformin to activate AMPK and monitored for the
development of hepatic tumors. The results from these experiments will provide proof-of-concept for the role of
Nod2 in activation of the AMPK pathway and for the role of this pathway in protection from the development of
hepatocellular carcinoma and will provide preliminary data for future in-depth studies to determine the
molecular basis of obesity-dependent liver cancer.

Public health relevance
The current project will identify the role of innate immunity proteins in the susceptibility to obesity-dependent liver cancer in mice. The proposed research is relevant to public health because the current prevention and treatment of obesity and obesity-associated liver diseases is inadequate, and this research will allow future development of new prevention and treatment methods. This research is relevant to the part of NIH mission pertaining to the treatment and prevention of obesity and obesity-associated liver diseases.